NIH NATIONAL BRAIN AND TISSUE REPOSITORY

This contract is for post-mortem human brain collection sites (i.e. the NIH Brain and Tissue Repositories [NBTR]) for the NIH NeuroBioBank. This contract is part of a strategy by the NIH to maximize availability of post-mortem human biospecimens to the research community while simultaneously achieving greater efficiency and better coordination of brain and tissue repository resources through a centralized approach to brain banking."

Public health relevance
This contract is for post-mortem human brain collection sites (i.e. the NIH Brain and Tissue Repositories [NBTR]) for the NIH NeuroBioBank. This contract is part of a strategy by the NIH to maximize availability of post-mortem human biospecimens to the research community while simultaneously achieving greater efficiency and better coordination of brain and tissue repository resources through a centralized approach to brain banking."